Culture, Longitudinal Patterns, and Safety Promotion of Handgun Carrying Among Rural Adolescents: Implications for Injury Prevention

Project Abstract
Firearm-related injury remains a leading cause of death among adolescents and young adults in the United
States. Firearm-related injury mortality rates are remarkably similar in rural communities and urban settings.
Handgun carrying is widely recognized as a key risk factor for firearm-related injury, violence, and crime
among adolescents in urban settings. It is not clear if these findings generalize to rural communities. A sizable
number of firearm-related homicides, suicides, and nonfatal crimes among adolescents in rural communities
involve handguns; however, our knowledge of the culture, scope, and developmental patterns of handgun
carrying in this population is strikingly limited. Identifying the antecedents and consequences of handgun
carrying and developing culturally-appropriate and community-specific interventions that promote prosocial
behavior while respecting the distinct rural firearm culture may translate to a lower burden of firearm-related
injury among adolescents in rural communities. We propose a project in response to “Research Grants to
Prevent Firearm-Related Violence and Injuries (R01)” to improve our understanding of handgun carrying
among adolescents in rural communities and provide a strong foundation for effective interventions that
prevent firearm-related injury and promote safety in this population. In this project, we will address both
Research Objective One and Research Objective Two using Funding Option B indicated on the Notice
of Funding Opportunity. We will collect new data on handgun carrying by conducting focus groups among
adolescents aged 14-17 currently living in rural communities in Washington State and use existing data on
handgun carrying among a gender-balanced and diverse panel of 4,407 youth aged 12 years in 2005 living in
24 communities that participated in a 7-state randomized community trial of the Communities That Care
prevention system driven by the Social Development Model. The panel has been followed across 10 waves of
data collection through age 26 in 2019. We will also collect new data related to handguns in the next wave of
this longitudinal study in 2021 when the sample is, on average, 28 years old. In this project, we will improve our
understanding of the cultural and environmental context within which handgun carrying occurs (Aim 1), identify
developmental patterns of this behavior among youth in rural communities during adolescence and as they
transition to adulthood (Aim 2), examine the salient antecedents and consequences of this behavior (Aim 3),
and test the effect of a prevention system on its patterns (Aim 4). Qualitative methods (e.g., thematic coding
and qualitative comparative analysis) and quantitative methods (e.g., latent growth mixture modeling and multi-
level mixed effects modeling) will be used to address these aims. Rural communities have high levels of
firearm access and mortality, yet they are understudied and underserved. This project will inform the
development, adoption, and refinement of non-punitive prevention approaches to address factors that influence
handgun carrying and reduce the burden of firearm-related injury among youth in rural communities.

Public health relevance
Project Narrative Handgun carrying is widely recognized as a key risk factor for firearm-related injury and violence among youth living in urban areas. Our knowledge of the culture, scope, and developmental patterns of handgun carrying, as well as its determinants and consequences, among youth living in rural communities is strikingly limited. The goal of this project is to fill this knowledge gap and provide actionable evidence for informing strategies that can prevent firearm-related injury and promote safety among adolescents in rural communities.